UNDERSTANDING THE INTERACTIONS BETWEEN GERMLINE AND SOMATIC ALTERATIONS in the PATHOGENESIS OF GLIOMAS

Provocative Question 3: Supplemental Application Summary/Abstract
This supplement application is being submitted in response to the Notice of Special Interest
(NOSI) identified as NOT-CA-22-057, “Administrative Supplements to Strengthen Global Cancer
Health Disparities.” This is a supplement to the parent R01 project of Dr. Robert Jenkins:
Understanding the interactions between germline and somatic alterations in the pathogenesis of
gliomas (CA230712), which was funded in response to Provocative Question #3, “Do genetic
interactions between germline variants and somatic mutations contribute to differences in tumor
evolution?” Prior to 2016, the diagnosis of central nervous system (CNS) tumors was based on
histologic features. In 2016, the World Health Organization (WHO) adopted a diagnostic
approach that integrates histologic appearance with acquired molecular alterations. In 2021,
these criteria were updated with many more molecular markers associated with various brain
tumor subtypes. Africa, and by extension Nigeria, lags behind in this field for various reasons,
including limited technical know-how in terms of molecular methods and the lack of resources
and equipment to perform molecular analyses for neuro-oncology cases. This supplement aims
to match the histologic characteristics of cases of gliomas diagnosed over the last nine years in
Lagos University Teaching Hospital, Lagos Nigeria, with molecular signatures. This study will be
the first molecular study of glioma in Nigeria, and therefore will give insight into the molecular
features (including both acquired and germline molecular alterations) of CNS tumors in Nigeria.
Supplement Specific Aim1 will perform targeted clinical sequencing and copy number profiling
on 60 global African glioma subjects from Lagos University Teaching Hospital. Supplement
Specific Aim 2 will build a collaborative consortium of global African sites to further study the
acquired and germline genetics of glioma. The parent NCI Provocative Question R01 grant (R01
CA230712) is aimed at evaluating the interaction between germline and acquired genetic
alterations in adult diffuse glioma with the underlying hypothesis that germline variants interact
with somatic alterations to accelerate the development of IDH-mutant and IDH wild-type
gliomas. The specific aims of the parent R01 are: Parent Specific Aim 1: To identify novel
germline risk variants that are associated with clinically-defined glioma molecular subtypes.
Parent Specific Aim 2: To evaluate the clinical relevance of combined germline and somatic
alterations associated with IDH-mutant glioma. Parent Specific Aim 3: To characterize the
functional implication of the known and newly identified glioma germline variants in the context
of IDH-mutant glioma. Thus, the proposed supplement aims are a natural extension to the
parent R01 by extending studies to patients with glioma in sub-Saharan Africa.

Public health relevance
Provocative Question 3: Supplemental Project Narrative This is a supplemental application that is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-22-057: “Administrative Supplements to Strengthen Global Cancer Health Disparities.” This is a supplement to the parent R01 project of Dr. Robert Jenkins: Understanding the interactions between germline and somatic alterations in the pathogenesis of gliomas (CA230712), which was funded in response to Provocative Question #3, “Do genetic interactions between germline variants and somatic mutations contribute to differences in tumor evolution?” The supplement application is a natural extension to the parent R01 and proposes to study the genetics of patients with glioma in sub-Saharan Africa.